Development of beam-offset optical coherence tomography

Project Summary
For cellular imaging in deep tissue, adaptive optics OCT (AO-OCT) has been intensively developed by
reshaping the wavefront of the illumination beam to focus the beam to diffraction-limited point spread
function (PSF) in a targeted region. Due to its complexity, cost, and size, wavefront sensor-based AO-OCT
is challenging to be translated into clinics. Less complicated sensorless AO-OCT(SAO-OCT) optimizes
the PSF using image metrics, but cannot ensure global optimization and is susceptible to motion artifacts
because image metrics must be strong and steady during the optimizing iteration. A trained Artificial neuron
network (ANNs) can optimize the wavefront immediately, much more efficiently than the conventional
optimization through multiple iterations. However, training ANNs with the image metric limits the
generality of the ANN. We believe that the best metric for SAO-OCT should be either the PSF or its
frequency domain equivalent, modulated transfer function (MTF), as they are the goals for optimization
and are independent of the imaged subjects and system optics. However, the technology of accessing
PSF/MTF in a scattering medium with OCT has not been proposed.OCT images originate from
backscattered photons due to refractive index variation in tissue. New contrast, tissue property-related
optical attenuation coefficient (OAC), has been extensively investigated to improve the diagnostic
capability of OCT. However, deriving OAC is mainly based on the single-scattering model, which ignores
MSPs, as conventional OCT cannot distinguish LSPs and MSPs. In addition, the single-scattering model
relies on at least three interdependent parameters. Prior knowledge is needed to ensure deriving OAC
successfully, but obtaining it in a clinical setting is not practical. These limitations have prohibited OAC
measuring from being translated into clinics. Here, we propose reconstructing backscattered photon
distribution(BPD) in a scattering medium with beam-offset OCT (BO-OCT) to resolve the above
challenges. In conventional OCT, the illumination and detection beams share the same optical paths. In
BO-OCT, the detection beam acquires images at offset positions from the illumination beam. The BPD can
then be reconstructed with the offset images. Our theoretical prediction and preliminary data show that the
distribution of LSPs is equivalent to the depth-resolved MTF, suggesting SAO-OCT can be implemented
using the MTF as the metric. With the BPD, we also show it is feasible to separate LSPs and MSPs, allowing
for accurately retrieving OAC by using just the LSPs to fit the single-scattering model. Real-time accessing
focal depth and Rayleigh range through the BPD allow incorporating the variation of these parameters into
modeling, suggesting a new method immune from motion artifacts.

Public health relevance
Project Narrative Optical coherence tomography (OCT) is an important imaging modality in clinics. We will develop and validate a novel concept of OCT that significantly improves OCT clinical diagnostic capability, especially for high resolution deep tissue imaging and measure tissue optical property.